Improving egg quality through an engineered biomimetic follicular microenvironment

PROJECT SUMMARY
The follicle is the functional unit of the ovary composed of an oocyte surrounded by somatic support cells,
including granulosa and theca cells. During folliculogenesis, bi-directional communication between the oocyte
and the granulosa cells s accumulation of maternal RNAs, proteins, organelles, and other factors that sustain
early developmental events prior to zygotic genome activation, including meiotic maturation, fertilization, and
early preimplantation embryo development. Thus, folliculogenesis is an essential process. Over the past several
decades, the development of ex vivo ovarian follicle culture techniques has provided a tightly controlled model
system to study follicle-intrinsic processes independent of the ovarian microenvironment. There are many
successful culture techniques, and one of the most frequently used methods across species involves
encapsulation of follicles in alginate-based hydrogels which mimics the three-dimensional architecture of the
follicle. These culture methods have revealed key details about the hormonal, molecular, and biomechanical
factors important for folliculogenesis and ovulation. Despite these advancements, existing approaches of ex vivo
follicle culture are technically demanding and are low throughput. One of the most critical challenges is that
these systems produce a consistently low yield of high-quality eggs capable of supporting preimplantation
embryo development. In this application, we will engineer a scaffold-free platform that better mimics ovarian
biology with the aim to improve the developmental competence of the resulting gamete following ex vivo follicle
culture. Through two specific aims, we will integrate and leverage a tunable agarose microwell design, timelapse
imaging, and microfluidic culture to develop a follicle culture system capable of producing high-quality gametes.
First, we will identify the ideal conditions for culture of high-quality follicles by engineering agarose molds that
impart different biomechanical properties on the growing follicle and hone the timing of ovulation using growth
parameters of individual follicles based on timelapse imaging. Second, we will use a microphysiological system
to determine the effect of dynamic exchanges of fresh and conditioned media that better mimics in vivo nutrient
delivery, hormone fluctuations, and waste disposal. The primary endpoints of the study will focus on the quality
of the resulting eggs assessed by their ability to yield high-quality preimplantation embryos, which will be
monitored by the Embryoscope™ time-lapse system. Our aims merge reproductive biology with innovative
bioengineering techniques, which is an essential partnership for developing a biomimetic follicle culture platform
that supports maximal egg and embryo quality. This research is expected to create a scalable and accessible
tool for basic ovarian biology research and represents a necessary first step towards the clinical translation of
this method in the context of fertility preservation.

Public health relevance
PROJECT NARRATIVE Female gametes grow and develop within ovarian follicles, and this microenvironment impacts gamete quality and fertility. The ability to grow follicles ex vivo in a manner that faithfully recapitulates what occurs in the body provides an important platform to study fundamental biology but also enables ex vivo drug and toxicology screening and fertility preservation options for individuals undergoing treatments which threaten ovarian function. Here we will use a customizable, biomimetic follicle culture approach combined with microphysiological technologies to engineer optimal culture conditions to grow follicles that yield the highest quality eggs and embryos.